A general, virus-free platform to rapidly map SARS-CoV-2 drug resistance

PROJECT SUMMARY
Development or repurposing of drugs for SARS-CoV-2 that causes COVID-19 is an active area of research,
but not much effort is being spent on developing platforms to identify mutations that may merge to the inhibitors
or neutralizing agents for these targets. Given the widespread prevalence of SARS-CoV-2 and potential abuse
of developed therapeutic agents, the emergence of such escape mutants is likely. We will develop a virus-free
platform to identify and validate escape mutants for therapeutic agents in the pipeline for SARS-CoV-2.

Public health relevance
PROJECT NARRATIVE Using cell-based and synthetic biology technologies, we propose to develop a virus-free platform to identify and validate mutants of SARS-CoV-2 proteins (e.g., spike, proteases, RdRP) that may emerge for theirs inhibitors or neutralizing agents.